Allogeneic cytotoxic gammadelta T cells for HIV cure immunotherapy

Allogeneic cytotoxic γδ T cells for HIV cure immunotherapy
PROJECT SUMMARY
HIV Cure strategies based on the “shock and kill” approach require the use of compounds to reactivate HIV from
latency and potent immune responses to eliminate HIV-infected cells. Efforts have mostly focused on enhancing
HIV-specific CD8 T cell responses but have faced a number of limitations including viral escape, immune
exhaustion and inaccessibility to the B cell follicle. γδ T cells, specially the most abundant peripheral blood
population, Vδ2 cells, constitute an attractive alternative cytotoxic cell population with unique properties largely
exploited in adoptive cell therapies for different malignancies that we have started to explore for HIV cure
purposes.
In our previous studies, we showed that autologous Vδ2 γδ T cells from people living with HIV (PLWH) ART-
suppressed are particularly effective inhibiting HIV replication and the first evidence that expanded Vδ2 cells
target and eliminate HIV-infected resting CD4 T (rCD4) T cells after latency reversal. These studies constitute
the basis for further investigation towards translating this alternative approach into the clinic. Vδ2 cells recognize
intermediates of the mevalonate pathway in an MHC-unrestricted fashion. They respond to a given challenge by
both up and/or downregulating specific receptors depending on the infectious/malignant environment displaying
a unique functional plasticity that enables them i) to exert direct cytotoxicity and ii) to initiate and boost adaptive
immune responses. Vδ2 cell phenotype can be shaped by ex vivo manipulating the mevalonate pathway using
Aminobisphosphonates (nBPs) and IL-2 or IL-15 leading to Vδ2 cell activation and expansion. Similarly, to NK
cells, combination of IL-2 and IL-15 with other cytokines and factors may favor the development of an effector
memory phenotype with enhanced cytolytic activity against HIV-infected cells. Additionally, the lack of MHC
restriction would allow for an allogeneic adoptive γδ T cell immunotherapy, that would be required for HIV cure
since Vδ2 cells are targets of HIV infection. Allogeneic adoptive cell transfer has been explored in the cancer
field and merits further investigation for HIV cure. Exploiting these unique features would allow the generation of
a cytotoxic effector population with phenotypic and functional properties suited for targeting reactivated HIV-
infected cells.
Given Vδ2 cell functional plasticity, we hypothesize that manipulation of the mevalonate pathway and proper
cytokine combinations will allow generation of a universal cytotoxic effector cell product of ex vivo expanded
allogeneic Vδ2 cells that will recognize and kill HIV-infected cells upon latency reversal. These hypotheses will
be addressed in the experiments of the following Specific Aims: (1) to determine whether allogeneic expanded
Vδ2 cells efficiently target and eliminate HIV-infected cells upon latency reversal and (2)
to explore conditions to
develop a universal immunotherapy Vδ2 effector cell product for HIV cure, and mechanisms of HIV-infected cell
recognition.

Public health relevance
PROJECT NARRATIVE Despite recent advancements in the clinical use of immunotherapies based on γδ T cells for the treatment of several cancers, the field requires further understanding of their unique phenotype and recognition system to effectively translate this approach in the clinic to cure HIV.